Career Enhancement Program

PROJECT SUMMARY/ABSTRACT: CAREER ENHANCEMENT PROGRAM
The Vanderbilt-Ingram Cancer Center (VICC), Vanderbilt University Medical Center (VUMC), and Vanderbilt
University (VU), collectively referred to as “Vanderbilt”, are deeply invested in continuously expanding the
quantity and quality of opportunities for career-long training in translational research available to physicians,
physician-scientists and researchers across the continuum from basic to translational to clinical to population-
based science. The NCI-funded Vanderbilt SPORE programs have played an integral role in enhancing the
careers of many faculty members and catalyzing talented basic scientists to translate their fundamental
discoveries to translational endpoints, as evidenced by projects in the current and proposed SPORE. VUMC
has 44 NIH and other federal institutional training grants. It is home to seven K12s, Vanderbilt's Clinical and
Translational Research Scholars KL2 awards from the Clinical and Translational Science Award (CTSA), and
numerous individual K awardees. Each year more than 300 trainees are appointed to career development
programs including T32s, F31s, F32s, and K awards or the equivalent. The majority of trainees are engaged in
collaborative work that has direct implications for human health, healthcare or population health. These actions
are of vital importance for the success of the Breast SPORE, as well as for our ultimate goal: a reduction in the
incidence, morbidity and mortality resulting from breast cancer. To achieve these overall goals, the SPORE
includes a Career Enhancement Program (CEP) with two complementary areas of career enhancement focus:
a physician-scientist/translational investigator (MD and MD/PhD) and a basic or population research scientist
(PhD). For the first area of focus, the Breast SPORE has built upon two successful NIH funded training
programs: the Vanderbilt Physician Scientist Development (VPSD) Program and the Vanderbilt Clinical
Oncology Research Career Development Program (VCORCDP, K12). The second area of focus of the CEP is
geared towards early, mid-career or senior basic scientists (PhDs) who wish to focus their research in breast
cancer. Our highly successful CEP has supported eleven investigators (thirteen total awards) in the current
funding period; three physician-scientists and eight basic scientists. Thirty publications have resulted from CEP
awardees. Six of the awardees have obtained extramural grants for a total combined budget of over $9.3M
(total costs). In addition, several CEP recipients have become major contributors in the competitive renewal of
the Breast SPORE with two awardees co-leading two of the translational projects in the proposed SPORE; two
other awardees working with project leaders as basic co-investigators and one awardee working with core
directors as a co-investigator. The CEP will continue to (1) provide translational research mentorship, training
and opportunities for investigators to develop the knowledge, skills and expertise to successfully pursue
independent, extramurally-funded careers focused in translational research in breast cancer, and (2) make it a
high priority to recruit underrepresented investigators into breast cancer research.

Public health relevance
PROJECT NARRATIVE: CAREER ENHANCEMENT PROGRAM The Career Enhancement Program (CEP) has two complementary areas of career enhancement focus: a physician-scientist/translational investigator (MD and MD/PhD) and a basic or population research scientist (PhD). We strongly believe that this dual pathway is highly relevant and important in order to recruit the best institutional talent into research domains that can eventually lead for the successful reduction in the incidence, morbidity and mortality resulting from breast cancer.